CRCNS: Computational Mechanisms for State-Driven Active Sensing

PROJECT SUMMARY (See instructions):
Humans and other animals exhibit a critical behavioral phenomenon in the control of movement: they
switch between two distinct modes-fast, exploratory "active sensing" and slower, goal-directed "task
control." This proposal aims to uncover the computational, behavioral, and neural mechanisms that
regulate these two modes. We hypothesize that animals use internal estimates of sensory uncertainty to
decide when to switch between modes, with uncertainty thresholds triggering transitions between
exploratory and goal-driven behavior. To test this, we will use a uniquely tractable animal model-weakly
electric fish performing a refuge tracking task-in which behavior, sensory feedback, and
neurophysiology can be measured and manipulated in real time. The project comprises three specific
aims: (1) develop computational models and theoretical tools to identify how and why animals switch
between active sensing and task control modes; (2) conduct high-throughput behavioral experiments to
quantify how sensory salience and feedback influence mode switching and control strategies; and (3)
perform neurophysiological recordings to identify neural correlates of locomotor control policies and
mode switching in the brain. This multidisciplinary effort integrates control theory, machine learning, and
neuroscience to reveal the computational strategies underlying the regulation of active sensing and task
control. Our findings have the potential to transform our understanding of biological motor control, identify
mechanisms for assessing sensory uncertainty, and advance strategies for movement control in complex
environments.

Public health relevance
RELEVANCE (See instructions): This research aims to uncover how the brain generates and uses small, fast "active sensing" movements to enhance behavioral control-mechanisms that are fundamental to everyday actions such as walking, reaching, and grasping. Conditions like aging, stroke, and diabetes can impair sensory feedback, disrupting these actions and diminishing quality of life. Based on internal estimates of uncertainty, we investigate how the nervous system dynamically balances active sensing and goal-directed control which may reveal new strategies for evaluating and treating movement disorders by targeting the feedback processes that support motor control.